Spatiotemporal Patterns of Network Dysfunction in Alzheimer's Disease

? DESCRIPTION (provided by applicant): Alzheimer's disease (AD) is the most frequent neurodegenerative disorder and the most common cause of dementia in the elderly. Unfortunately, there are still no effective treatments to prevent, halt, or reverse AD. As new clinical trials focus on the initial stages of disease, early diagnosis is now more important than ever. Human neuroimaging has greatly improved our knowledge of this disease by demonstrating selectively vulnerable large-scale networks whose connectivity declines in AD. Transgenic mouse models of AD have identified specific brain regions whose aberrant excitatory activity causes neuronal network dysfunction. However, the exact relationship between neural network abnormalities in animal models with that in the human condition remains unknown. To better understand the altered neural dynamics underlying clinical symptoms in AD will require novel techniques and methodologies. Speech and language abnormalities are evident in AD patients from the very early stages of the disease. We propose to use a novel magnetoencephalographic imaging (MEGI) approach to determine the speech- motor-network deficits of AD-spectrum patients. MEGI provides direct recordings of brain activity with precise millisecond resolution. The goal of this study is to understand the spatial patterns and temporal dynamics of speech encoding and speech execution in AD patients. Using customized software we will measure brain activity patterns across high and low frequency bands. We expect to find unique signatures of speech-motor- network dysconnectivity in AD. Such knowledge will be related to underlying synaptic dysfunctions of vulnerable neuronal populations as early biomarkers of the disease and will have important implications for translational research. The candidate is a physician-scientist with a strong commitment to a career in neurodegenerative dementia research. The candidate has an MD and a PhD in cognition and neuroscience. The research proposal and career development plan build upon her training in rodent neurophysiology and auditory and speech processing to provide expertise in human brain connectivity and its relationship to cognitive deficits in AD. Dr. Keith Vossel, a physician-scientist who cares for patients with dementia and specializes in transgenic mouse models of neurodegenerative disease, is the candidate's sponsor. The mentoring and research experience described in this proposal will facilitate the candidate's goal of developing a strong independent research career.

Public health relevance
PUBLIC HEALTH RELEVANCE: Alzheimer's disease (AD) is the most common form of dementia and currently has no cure. This study will use the novel and promising technique of magnetoencephalographic imaging in AD patients to characterize abnormal neural firing associated with some of the earliest cognitive deficits of speech and language dysfunction in AD. A better understanding of the neurobehavioral associations is crucial for designing and developing disease-modifying strategies to counter this debilitating disease.